Norepinephrine-mediated resistance to nutritional immunity in Neisseria gonorrhoeae

PROJECT SUMMARY / ABSTRACT
Neisseria gonorrhoeae (Gc) is the bacterial pathogen responsible for the sexually transmitted infection
gonorrhea, which causes an estimated 87 million cases globally each year. As cases and antibiotic resistance
increase, new approaches to treat and prevent gonorrhea are high priority. Gc promotes a robust inflammatory
response characterized by neutrophil recruitment. Despite this, neutrophils are insufficient to eliminate Gc.
Untreated gonococcal disease can cause pelvic inflammatory disease, ectopic pregnancies, and infertility. To
limit infection, the host uses nutritional immunity: sequestration of essential metals like iron from pathogens.
During infection, Gc is under continual stress to acquire iron for survival and replication, but its adaptation to low-
iron conditions during neutrophil challenge remains unclear. This F30 proposal is based on my discovery that
while Gc does not survive in iron-limited medium, it grows in neutrophil supernatants collected in this medium. I
found that neutrophils do not release iron, but rather release norepinephrine that enables Gc to overcome iron
restriction. Norepinephrine is known for its role as a neuroendocrine hormone. However, it has been shown to
have non-canonical roles in supporting microbial growth and virulence in other bacterial pathogens, primarily by
acting as a trans-kingdom signal and/or pseudo-siderophore. While norepinephrine has been shown to strip iron
from iron-sequestering proteins like transferrin, I found that norepinephrine enhanced Gc growth in protein-free
media. I also found that Gc response to norepinephrine is blocked by α-adrenergic antagonist phentolamine and
is independent of TonB, which powers outer membrane iron transporters. Thus, norepinephrine-enhanced Gc
growth may involve mechanisms that cannot be explained by our current understanding of Gc iron acquisition. I
hypothesize that Gc senses host-derived norepinephrine and responds by altering bacterial physiology to better
cope with iron limitation during infection. In Aim 1, I will characterize how norepinephrine impacts iron availability
in Gc by assessing changes in total iron, labile iron, and iron-dependent gene expression. This will inform our
understanding of how norepinephrine changes Gc physiology to withstand iron limitation. In Aim 2, I will identify
and characterize gonococcal gene product(s), including putative norepinephrine sensors, that enable Gc to
respond to norepinephrine. This Aim will uncover how Gc exploits norepinephrine to resist iron
starvation. Altogether, the research proposed in this F30 application will expand our understanding of how Gc
senses and adapts to the inflammatory environment to overcome nutritional immunity during infection of host
mucosal sites. The findings may lead to new drug and vaccine targets to combat gonococcal disease. These
efforts and complementary activities planned under this award will provide me with the training and expertise to
achieve my career goal of becoming a physician-scientist specializing in molecular mechanisms of microbial
pathogenesis and reproductive infectious disease.

Public health relevance
PROJECT NARRATIVE Neisseria gonorrhoeae (Gc) is the causative agent of the sexually transmitted infection gonorrhea, which is an urgent public health threat with increasing cases, rising antibiotic resistance, and severe clinical sequalae. This proposal seeks to determine how Gc senses and responds to norepinephrine released by neutrophils to tolerate iron limitation during infection. By investigating these mechanisms, this work will lay the groundwork for the development of therapeutics and vaccines that target this high-priority pathogen.